Center for Modeling Non-Coding Disease Variants

PROJECT SUMMARY/ABSTRACT: OVERALL APPLICATION
Ninety-eight percent of the human genome is non-coding. Moreover, extensive analyses of common and rare
diseases have implicated these noncoding genomic regions as a significant factor. For example, 90% of SNP-
disease associations identified through Genome-Wide Association Studies are located in non-coding regions
and 60% of genetic tests in rare disease patients produces unresolved associations. Despite this, the link
between noncoding variants and human disease remains poorly understood due to challenges in mapping these
regions, difficulties in detecting their activity, and a lack of experimental models to dissect their roles in biology.
To address these challenges, we propose establishing a Center for Noncoding Disease Variant (NODIVA). We
leverage access to national rare and undiagnosed disease consortia as a platform to test high-penetrance
disease associations. Our team has been at the forefront of these efforts, generating some of the few available
knock-out and knock-in models of non-coding regulatory regions associated with development and disease. In
recent years, we have developed innovative tools to improve the ability to 1) detect, 2) quantify, and 3) link to a
genomic activity most noncoding loci, as well as high-throughput in vitro and in vivo systems to genetically
modulate and mechanistically dissect these regulatory elements. The goal of our Center is to develop targeted
experimental disease models of noncoding variants in mice and human pluripotent stem cells (hPSCs) and share
the knowledge and resources generated by these models. Our specific aims are to 1) leverage large-scale rare
disease discovery cohorts from both internal and external sources; 2) apply novel computational and functional
approaches to analyze, prioritize and screen noncoding variants, from variants of unknown significance to likely
pathogenic mutations; 3) generate disease models of noncoding variants with high potential for causing disease
in mice and model disease mechanisms in hPSCs; and 4) disseminate these models and work with internal and
community referral researchers to generate and interpret cellular and molecular phenotypes from patient and
animal models. We believe our proposal will be transformative, addressing critical gaps in current rare disease
research by providing innovative disease models and integrative frameworks that will advance the field and
ultimately improve patient outcomes.

Public health relevance
PROJECT NARRATIVE: OVERALL APPLICATION Ninety-eight percent of the human genome is composed of noncoding DNA. When modelled and tested in detail, these noncoding regions (e.g., enhancers, silencers, regulatory RNAs, untranslated regions) have been shown to play essential roles in regulating gene expression and cellular functions. Analyses of both common and rare disease genetics indicate that a vast proportion of disease associations fall into noncoding regions of the genome. A lack in robust analytical, technical, and experimental models to systematically dissect underlying associations hinders scientific progress in this domain. To address this critical gap in basic knowledge that has clearly important translational clinical outcomes, we plan to establish a Center for modeling noncoding disease variants with the aim of understanding how noncoding genetic variation contributes to a vast array of diseases.